Administrative Core

PROJECT SUMMARY/ABSTRACT
Lung recipients suffer from shorter life spans and higher rejection rates when compared to other solid organ
recipients. To better advance a program project focused on the mechanisms of lung transplant rejection an
administrative core is proposed with three specific aims: (1) to organize and facilitate communication between
three projects and the microsurgical core (2) to maximize the use of fiscal resources and (3) to assemble a
scientific advisory committee. This administrative core will consist of a core leader, an administrative lead and a
biostatistician, who will provide statistical support for each of the projects. The overall goal of the administrative
core is to leverage the intellectual and financial resources of the individual projects to maximize overall scientific
productivity.